Analysis of the heterogeneity of cell death responses in the influenza virus-infected cells

Summary
Efficient treatment of severe influenza remains a significant unmet medical need, as this disease causes
hundreds of thousands of hospitalizations and tens of thousands of deaths every year. Severe flu cases are
associated with extensive cell death of the lung epithelial cells, causing the loss of lung oxygen exchange
function, which can be fatal even if the virus is efficiently cleared. On the other hand, cell death is an essential
component of the innate immune response, helping eliminate infected cells and prime the adaptive immune
response. Critical anti-viral transcriptional programs, such as activation of the interferon responses and synthesis
of a variety of additional cytokines and chemokines, also intertwine with different forms of cell death to shape
host defense. Furthermore, recent evidence suggests that not all flu-infected cells are eliminated through cell
death; a subset can survive and clear the virus through non-lethal means. Depending on the context, these
“persister” populations may either contribute to lung repair or drive long-term inflammatory pathology (i.e., long
flu). Given these complexities, to target cell death therapeutically, it is critical to understand the interplay of the
transcriptional and cell death responses to elucidate which cell death events can be stopped safely without
compromising viral clearance. However, the challenge for accurately interpreting the transcriptional dynamics of
a population of cells asynchronously undergoing cell death is the lack of RNA-seq-compatible readouts that
measure the cell death status of each cell and, thereby, allow differentiation of the persisters from the cells that
have initiated or executed cell death. We propose to address this challenge using a new scAnnexinV-seq assay
that we recently developed, which allows the linking of each cell's transcriptome to its cell death status. This is
accomplished by conversion of a frequently used Annexin V/PI live/dead assay into a format that can be read
out during scRNA-seq analysis. In Aim 1, we will optimize scAnnexinV-seq using a simple in vitro system of
primary macrophages induced to undergo a particularly pathogenic form of cell death - necroptosis. Aim 2 will
further adapt scAnnexinV-seq to analyze the more complex and biologically relevant model system –
transcriptional and cell death dynamics in the IAV-infected primary Type I alveolar epithelial cells at a single cell
level. For these experiments, our assay will be expanded to include additional readouts monitoring the viral
infection status of each cell. The proposed studies will provide a valuable new approach to understanding cell
fates consequential to viral infections.

Public health relevance
PROJECT NARRATIVE Host defense against viral infections involves an intricate interplay between gene expression changes that help restrict viral replication and recruit immune cells, and cell death, which helps eliminate infected cells. Understanding of these mechanisms is further complicated because death of individual cells in a population occurs asynchronously, and individual cells have different capacities to activate cell death. To address the complexities of these responses, we are developing a new assay that allows the correlation of gene expression, cell death, and infection status of each individual cell, and propose to use it to characterize responses to influenza virus infection in the lung cells.